Using microgravity to model inflammaging in complex organ chip models of heart, gut, and brain

PROJECT SUMMARY/ABSTRACT
Cellular aging, characterized by the accumulation of damaged proteins and senescent cells, leads to
functional decline in the heart, brain, and intestine, increasing susceptibility to age-related diseases.
Monocytes and macrophages play crucial roles in tissue development and repair, but their function can decline
with age, contributing to chronic inflammation known as "inflammaging." Recent studies indicate that
spaceflight can also alter monocyte and macrophage functionality, simulating aspects of aging and
inflammation. Microphysiological systems (MPS) represent an innovative approach to replicate complex human
tissue environments, augmenting traditional 2D cultures, and will be employed in this study to assess aging
phenotypes in microgravity. This proposal seeks to explore the impact of spaceflight-induced aging and
inflammaging on various tissue types using multi-lineage (MPS). The research will be conducted in two
phases: the UG3 phase will establish MPS-based models for accelerated aging harboring human induced
pluripotent stem cell (hiPSC)-derived tissues, whereas the UH3 phase will identify signatures of spaceflight-
induced cell aging and attempt to reverse them using senolytic strategies.
The hypothesis of this proposal is that multi-lineage MPS, also known as organ-on-chips, can serve as
a platform for elucidating the mechanisms of spaceflight-induced accelerated aging and tissue degradation.
This work builds upon the Principal Investigators’ (MPIs Sharma and Svendsen) existing studies utilizing MPS
systems to model human disease and employing hiPSCs to explore human physiology and biomanufacturing
in space. Aim 1 of this proposal is to develop hiPSC-derived, multi-lineage gut, brain, and heart MPS systems
and integrate with hiPSC-derived macrophages (iMACS) to examine tissue maturation and stability. Aim 1 will
utilize fluorescent reporter hiPSC lines, differentiation of hiPSCs into multiple lineages, in-space microscopy,
analysis of MPS effluent, and custom spaceflight-compatible MPS from implementation partner BioServe
Space Technologies. Aim 2 will examine the impact of spaceflight on altering aging-related biomarkers in
heart, brain, intestinal MPS models with or without iMACS. The MPS will be subjected to microgravity in space
and their integrity, functionality, and transcriptomic/metabolomic profiles will be examined to determine the
impact of spaceflight on accelerated tissue and immune cell aging and degradation. Aim 3 will repeat the
spaceflight experiment proposed in Aim 2, and will also identify senescence-specific biomarkers in space-flown
iMACS and MPS and test senolytic compounds aiming to reverse microgravity-induced aging phenotypes.
Collaborations with experts in immune aging and spaceflight experience will bolster this project's
impact. Ultimately, findings will aim to translate insights gained in microgravity to improve human health on
Earth, via comprehensive in-flight and post-flight analyses in multi-lineage, hiPSC-derived MPS systems.

Public health relevance
PROJECT NARRATIVE Cellular aging in the heart, brain, and intestine results in functional decline and increased risk of age-related diseases due to the buildup of damaged proteins, senescent cells, and DNA mutations. The proposed study will utilize microphysiological systems (MPS) harboring human induced pluripotent stem cell (hiPSC)-derived tissues on the International Space Station to explore the effects of spaceflight on accelerating aging, tissue degradation, and inflammation. This project will 1) investigate microgravity-induced aging and tissue degradation in MPS harboring hiPSC-derived cardiovascular cells, intestinal organoids, neuronal cultures, and macrophages, 2) evaluate functional, cellular, and transcriptomic changes in hiPSC-derived cells grown on MPS in space, and 3) examine potential countermeasures to alleviate potential aging phenotypes in space and on Earth.